Transdermal estrogen for the treatment of bone loss in women with anorexia nervosa

Project Summary/Abstract
Anorexia Nervosa affects up to 2% of women in the US and is characterized by extreme, self-induced
starvation. Of the many medical co-morbidities associated with this disorder, severe bone loss is the most
common and often persists despite weight recovery. Importantly, this bone loss is associated with an increased
risk of fracture; a prospective study demonstrated that women with anorexia nervosa have a 7-fold increased
risk of fracture compared to age-matched controls. Therefore, a treatment to prevent the severe bone loss
associated with this disease is critical, but there are currently no approved treatments for anorexia nervosa-
associated bone loss. We have recently shown that 6 months of treatment with teriparatide increases lumbar
spine bone mineral density (BMD) by 6% in women with anorexia nervosa but use of teriparatide is only
approved for 24 months and the majority of patients live with this disease for decades. Bisphosphonates, which
increase BMD by 3-4% after 12 months of use, also have potential harmful effects with long-term use (ie
atypical femoral fractures with prolonged use). Therefore, an optimal treatment for bone loss in this disease will
not only effectively increase BMD, but will also be available for long-term use. Amenorrhea and resultant
hypoestrogenemia -- characteristic findings in women with anorexia nervosa -- are significant contributors to
the loss of bone mass in this disease. This is supported by the fact that duration of amenorrhea is directly
associated with low BMD in women with anorexia nervosa. Yet, despite this association, multiple studies
investigating the effects of oral estrogen in women with anorexia nervosa have not demonstrated a benefit.
Recently, transdermal estrogen has been shown to increase BMD in adolescent girls with anorexia nervosa but
whether transdermal estrogen will improve BMD in women with anorexia nervosa is not known. Prior treatment
studies have demonstrated distinctly different responses to treatments in adolescents with anorexia nervosa as
compared to adults. For example, although BMD in adult women increases by 3-4% in response to one-year
of bisphosphonate treatment, adolescents treated with bisphosphonates for one-year do not have a significant
increase in BMD compared to those treated with placebo. Therefore, treatments that may be effective in one
population may not be effective in the other. Our preliminary data demonstrate a 2.1% increase in spine BMD
in women with anorexia nervosa treated with 6 months of transdermal estrogen replacement coupled with a
decrease in marrow adipose tissue, a potential determinant of bone mass. Therefore, we propose to perform a
randomized, double-blind placebo-controlled study to investigate the effects of transdermal estrogen
replacement on bone mass, bone microarchitecture and marrow adipose tissue in adult women with anorexia
nervosa. By investigating associations between changes in bone mass, bone turnover markers and marrow
adipose tissue in response to transdermal estrogen, we also hope to gain a greater understanding of the
pathophysiology of bone loss in states of chronic undernutrition.

Public health relevance
Project Narrative Anorexia nervosa, a disorder that predominantly affects women, is characterized by extreme, self-induced weight loss and is associated with many medical complications including significant bone loss and an increased risk of fracture. Although most women with anorexia nervosa have low estrogen levels -- which may be an important contributor to the bone loss – oral estrogen does not increase bone mineral density in adult women with anorexia nervosa. We will study the effects of transdermal estrogen on bone mineral density, bone microarchitecture, and fracture in women with anorexia nervosa in a randomized, placebo-controlled study.